High dimensional digital pathology to investigate the tumor micro environment and its impact on response to therapy

Summary
Grant: Research Specialist (PAR-19-291)
Under the supervision of senior scientist Zoltan Maliga PhD, investigators and staff at the Harvard
Medical School Laboratory of Systems Pharmacology (LSP) will contribute to cell and tissue imaging
and analysis for U2C and U54 program grants
LSP-based investigators will perform the tissue-based cyclic immunofluorescence (t-CyCIF) method
developed at HMS on FFPE human and mouse skin samples provided by investigators and will work
together to define and validate antibodies to stain biomarkers of skin development, inflammation,
melanoma progression and tumor microenvironment and will share technologies under development
to further advance the t-CyCIF method (e.g. switch to six-channel imaging, use of oligo-modified
antibodies as detection reagents, combination of in situ hybridization or sequencing methods). The
LSP will process t-CyCIF images, provide quantitative cell and tissue-level analysis and help
distribute high-resolution multiplexed images as part of a disease pathology atlas.
Maliga will work with PIs Lian, Murphy, LeBoeuf, Haigis, Aster to prepare manuscripts, write reports
for the NIH and collaborate with other members of the project teams as required the by PAR-19-291.

Public health relevance
Project Narrative Grant: Research Specialist (PAR-19-291) Title: High dimensional digital pathology to investigate the tumor microenvironment and its impact on response to therapy This project involves developing a digital pathology platform for highly-multiplexed tissue imaging and data analysis to support NCI-funded grants, including the construction of a melanoma precancer atlas for the Cancer Moonshot Human Tumor Atlas Network. This proposal will also support original research to characterize the cutaneous immune landscape in cancer, autoimmune disease and adverse reactions to drug therapy. Finally, this grant will promote my career development as a research specialist and increase my independence as a scientist in the Laboratory of Systems Pharmacology at Harvard Medical School.